Generation of CD8+ Tissue-Resident Memory T cell response during Yersinia pseudotuberculosis foodborne infection

Project Summary/Abstract
The tissue resident memory T (TRM) cells that reside at barrier tissues respond immediately following pathogen
encounter. Eliciting TRM cells has become a priority in vaccine development to combat infectious diseases and
in cancer immunotherapy. Live attenuated Gram-negative bacterial pathogen Yersinia pseudotuberculosis (Yptb)
will be evaluated here as a new vaccine vector to produce antigen-specific intestinal CD8+ TRM cells. As a rare
pathogen, Yptb causes mostly self-limited mesenteric lymphadenitis in immune competent humans and is
treatable with antibiotics. Sub-lethal infection with Yptb in C57BL/6 mice elicits a large H-2Kb-restricted CD8+ T
cell response specific to bacterial epitope YopE69-77. Following foodborne infection, two different subsets of Yptb-
specific CD8+ TRM cells were identified in intestinal tissues: the scattered CD103+ and the clustered CD103neg
cells. The CD103+ cells depend on transforming growth factor-b (TGFb) and the CD103neg cells require
interferon-b (IFNb) and interleukin-12 (IL-12), inflammatory cytokines mostly generated from CCR2-dependent
cells.
Several unique characteristics of Yptb suggest that this previously overlooked pathogen is at an advantageous
position to be transformed into a vaccine vector. Yptb utilizes a type 3 secretion system (T3SS) to inject a set of
6-7 toxic effector proteins, collectively called Yops, from the bacterium directly into the cytosol of eukaryotic cells
during infection. Injection of these Yop effectors through the Yptb T3SS is contact dependent and following
mouse infection, a high percentage of phagocytes are among the targets. Therefore, the Yptb-based vaccine
vector introduces antigenic proteins directly into the cytosol of phagocytic antigen-presenting cells without the
need to manipulate the genome or transcriptome of eukaryotic cells. Studies are proposed here to initiate
investigation to understand the bacterial and cellular determinants of the two types of TRM generation. In addition,
because the Yop effectors interfere with host immune responses, efforts will be made to attenuate the Yptb-
based vaccine vector and increase its immunogenicity through inactivation of the relevant Yop effectors.
Moreover, because cytotoxic CD8+ T cell response is required to control Yptb even in the presence of protective
antibody response, the possibility that the attenuated Yptb vaccine vector can be introduced repeatedly to elicit
TRM cells with additional antigenic specificity will be evaluated. Accomplishing the studies proposed here will set
the foundation to develop a new type of live attenuated vaccine that is urgently needed for gut TRM cell generation.

Public health relevance
Project Narrative Studies proposed here aim at establishing a new type of live attenuated bacterial vaccine vector that effectively generates intestinal antigen-specific CD8+ tissue resident memory (TRM) cells. If proved, this new vaccine vector will be safe, effective, able to generate different types of TRM cells and suitable for repeated vaccination. With other benefits offered by live attenuated bacterial vaccine vectors, such as controllability through antibiotic treatment, ease of production, storage and transportation, and economic advantages, this new type of vaccine vector may revolutionize vaccine development and even cancer immunotherapies.